Core A - Administrative and Systems Biology of Aging Core (ASBC)

CORE A: Administrative and Systems Biology Core – SUMMARY
The Administrative and Systems Biology Core (ASBC, Core A), led by Drs. Nathan LeBrasseur and Sundeep
Khosla who have a longstanding and productive history of collaboration, will provide the overall leadership as
well as the infrastructure for the Program Project Grant (PPG). The three Projects defining mechanisms of
cellular senescence in skeletal aging (Project 1), muscle aging (Project 2), and brain aging (Project 3) in the
PPG represent independent but highly interactive proposals by experienced investigators who have a long track
record of collaborative studies. A major goal of Core A, therefore, is to ensure optimal interaction and integration
among the Projects. These interacting Projects also need the appropriate infrastructure and logistical support,
such as sample acquisition and storage, data management, and central administrative coordination. In addition,
as in the previous funding cycle, Core A will continue to provide statistical support to the investigators and
trainees associated with the Projects and, where appropriate, the Cores. However, in keeping with the evolving
bioinformatic needs of the Projects and also Core C (Drug Discovery and Development) and Core D
(Senescence Molecular Phenotyping), we have enlisted a highly qualified expert in systems biology and
bioinformatics, Dr. Hu Li, to (i) develop novel deep learning and systems biology platforms to uncover context-
specific mechanisms of aging-driven senescence in bone, muscle, and brain; and (ii) to devise and leverage
deep learning and systems-based single-cell analysis methods to decipher genes that modulate spatial
coordination of cells in the aging microenvironment. Collectively, through the coordination, integration, and
analysis of research activities and results across the three projects and four cores, Core A will ensure this PPG
yields fundamental insights into the governing roles of p16 and p21 in cellular senescence and aging, critical
data on the therapeutic potential of senotherapeutic compounds for age-related tissue dysfunction, and an
advanced understanding and new hypotheses regarding cellular senescence as a mediator of inter-organ
communication between bone, skeletal muscle, and brain.